Project 3 - The Critical Role of Membrane Transport

Project Summary – Project 3 – Targeting the Critical Role of Membrane Transporters
Mtb is an intracellular pathogen and thus is surrounded by a host cell. Because of this immersive
environment, Mtb membrane proteins constitute a direct functional interface between the pathogen and
its host. They sense the environment and control entry of nutrients and other molecules (including many
drugs) into, and exit from the organism. Thus, they offer a ‘gateway’ for small molecule therapeutics.
However, to date, there are only two high-resolution structures of Mtb integral membrane proteins due in
part to the difficulty of expression, purification and crystallization of membrane proteins, and to the lack
of focus onto Mtb. We have developed a general method to prioritize integral membrane proteins
identified as viable drug targets, essential genes, or critical virulence factors in Mtb. Our priorities continue
to be ranked in collaboration with members of the consortium, using preliminary drug targeting and
virulence screening data. Building on our expertise developed as a national center, we have also
developed robust methods to express, purify and crystallize integral membrane proteins for structure
determination by X-ray crystallography, and by electron cryo-microscopy.